Activation of androgen biosynthesis and drug metabolism by cytochrome b5

Abstract
Cytochrome b5 (b5) profoundly influences the catalytic efficiency of many cytochrome P450-catalyzed
reactions, yet the mechanism(s) of this action of b5 on P450 enzymes are controversial. Among these b5-
regulated activities is the 17,20-lyase activity of P450 17A1 (steroid 17-hydroxylase/17,20-lyase), which is a key
step in the biosynthesis of androgens. Diseases of androgen excess and androgen dependence, including
polycystic ovary syndrome and prostate cancer, are extremely common, and the P450 17A1 inhibitor abiraterone
acetate (AA) is used to treat prostate cancer, proving the relevance of P450 17A1 in human disease. AA inhibits
both the 17-hydroxylase and 17,20-lyase activities, and 17-hydroxylase inhibition causes accumulation of 11-
deoxycorticosterone, a mineralocorticoid that causes hypertension and potassium loss, unless a potent
glucocorticoid is co-administered. Consequently, an unmet clinical need is a selective inhibitor of the 17,20-lyase
reaction, which will more safely lower testosterone than AA. We hypothesize disruption of the allosteric effects
of b5 on P450 17A1 will selectively block the 17,20-lyase reaction and lower testosterone production without
disturbing drug metabolism or requiring chronic glucocorticoid therapy.
Our long-term goal is to elucidate the biochemical and biophysical properties of the b5-P450 17A1
complex that are required to catalyze the 17,20-lyase reaction. Our central hypothesis is that b5 binding
allosterically restricts the conformational dynamics of the P450 17A1-substrate complex, which maximizes the
coupling of the 17,20-lyase reaction. Consequently, the objectives of this renewal application are to define the
mechanism of b5 action on P450 17A1 during the 17,20-lyase reaction and to characterize the allosteric action
of b5 on the conformation dynamics of the b5-P450 17A1 complex on a range of timescales.
In Aim 1, we will dissect the mechanism of b5 action on the the 17,20-lyase reaction from the oxyferrous
P450 17A1-substrate complex through the second electron transfer and chemical steps, using stop-flow
spectroscopy and rapid chemical quench with a set of 17-hydroxysteroid substrates and a series of P450 17A1
and b5 mutations that disrupt 17,20-lyase activity. In Aim 2, we will reposition the cysteine residues P450 17A1
scaffold to insert fluorescent tags on specific residues. We will use these tagged P450 17A1 molecules in
phospholipid nanodiscs to study the regional dynamics of P450 17A1. In Aim 3, we will probe these changes in
native P450 17A1 conformational dynamics on the msec-sec time scale using hydrogen-deuterium exchange.
These experiments will systematically define the mechanism of action of b5 on the 17,20-lyase activity of P450
17A1. This knowledge will inform strategies to target the 17,20-lyase activity and to inhibit androgen (and
estrogen) production for the treatment of human diseases, without the limitations of current therapies.

Public health relevance
Project Narrative Testosterone, the “male hormone,” is important for men’s health and reproduction; however, testosterone causes or worsens common diseases, such as prostate cancer in 10% of men or polycystic ovary syndrome in 5-8% of reproductive-aged women. Testosterone production requires the enzyme cytochrome P450 17A1, and inhibitors of P450 17A1 are now used to treat prostate cancer—but—cause side effects including high blood pressure and low potassium. The purpose of this grant application is to understand the details about how P450 17A1 makes testosterone, so that we can develop better inhibitors, which eliminate testosterone production but do not have the side effects of the drugs that we currently use.